Genetic profiling of childhood glaucoma in India

Glaucoma is a clinically and genetically complex disease that is the leading cause of irreversible blindness
worldwide. The disease exhibits both complex and Mendelian inheritance with complex disease more common
in adult populations and Mendelian forms more common in children and young adults. While recent genome-
wide association studies (GWAS) have identified >100 risk loci for adult-onset disease, only 12 genes are
known to cause childhood glaucoma, and few studies have targeted this severely affected population. The
current set of childhood glaucoma genes can explain only 20% of cases, leaving most affected individuals
without a molecular diagnosis after genetic testing. Treatment options for childhood glaucoma cases are
limited and these patients are most likely to become blind during their lifetimes, especially in countries such as
India where many affected children are not diagnosed. This project will address the significant unmet need of
effective genetic testing for childhood glaucoma in India by completing large-scale genetic profiling of affected
children to assess the frequency and clinical correlation of causal mutations in currently known genes and to
discover novel genes responsible for this devastating disease. This project is a new collaboration between
India and U.S. investigators that addresses an important problem for both countries. We will accomplish the
following specific aims: 1) Using high quality whole exome sequence (WES) data for 480 childhood glaucoma
probands and family members in India we will apply QC metrics and best practice methods to identify rare
variants with features expected of pathogenic causal alleles. 2) Using in vitro and in vivo models we will
evaluate functional effects of novel childhood glaucoma genes and variants with an initial focus on PLOD2
variants already identified by our Indian colleagues in families with childhood glaucoma.

Public health relevance
Childhood glaucoma is an important cause of pediatric blindness worldwide, and particularly in countries such as India where many affected patients may be undiagnosed and treatment options are limited. Genetic testing while potentially useful, currently can only detect molecular diagnoses in 20% of childhood glaucoma cases worldwide. This project will complete large-scale genetic profiling of childhood glaucoma in India to improve genetic testing through discovery of novel genetic causality.